A Longitudinal Brain and Behavior Study of Autism From Infancy Through Adolescence

Project Summary
In this application we propose to overlay a ten-week summer fellowship research training program and virtual
outreach seminar series on career development, for under-represented minorities (URM) undergraduates
around the country, onto the existing infrastructure of the IBIS Network, to promote entry of URM
undergraduates into a career in autism research. URM undergraduates will be recruited at various sites of the
NIH-funded Infant Brain Imaging Study, around the country. They will work with a junior research trainee,
under the supervision of an established IBIS investigator. Participating trainees will attend local research lab
meetings, be assigned to a specific research project, observe all aspects of data collection, attend regular
network meetings and local didactic seminars, and meet regularly with members of the research team at all
levels and across all disciplines to discuss aspects of research content areas and professional development,
and be expected to produce a final written product on a relevant topic from their experience.

Public health relevance
Project Narrative This project proposes to conduct a summer training program in autism research for minoritized undergraduates, with the goal of potentially increasing the pool of under-represented minorities in the field of autism research.